CRISPR-Cas9 Genome Edited MSCs to Target OA Cartilage Regeneration

Project Summary
Cartilage defects in patients with knee osteoarthritis are often filled with fibrocartilage. Inflammation in joints
renders cartilage defects a refractory disease. Mesenchymal stromal/stem cells (MSCs), a promising cell
source for the treatment of cartilage defects, exhibit a site-dependent differentiation preference: bone marrow-
derived MSCs (BMSCs) exhibit chondrogenic differentiation but end with endochondral ossification; adipose-
derived MSCs (ADSCs) are readily available but have limited chondrogenic potential and tend toward
fibrocartilage instead of articular cartilage; and synovium-derived MSCs (SDSCs) are a tissue-specific stem
cell for chondrogenic differentiation but have limited accessibility. Moreover, a greater number of MSCs is
needed for tissue engineering and regeneration; however, MSCs are prone to become senescent during ex
vivo expansion leading to a loss of their proliferation and differentiation potentials. Given that MSCs and
fibrocartilage have extensive expression of collagen I (COL1A1), in this proposal, we hypothesize that
integration of OStrio (both OCT4 and SOX trio) at the COL1A1 locus allows for MSC rejuvenation and articular
differentiation while suppressing fibrocartilage by a negative feedback loop. To achieve this hypothesis, we
plan to use cutting-edge CRISPR-Cas9 Genome Editing technology for precise integration of OStrio at the
COL1A1 locus of MSCs (Aim 1), followed by fine-tuning of proliferation and chondrogenic differentiation of
OStrio-expressing MSCs via WNT signals (Aim 2); lastly, genetically engineered MSCs will be assessed in
vivo through subcutaneous implantation (with a sufficient vascular supply) of premature tissue constructs from
human OStrio-expressing MSCs in an immunodeficient mouse model for future clinical translation (Aim 3.1)
and intra-articular implantation of premature tissue constructs from rabbit OStrio-expressing MSCs in an
osteochondral defect rabbit model (Aim 3.2). Our expectation is that OStrio-expressing MSCs have superior
proliferation and chondrogenic differentiation capacity in an in vitro study as well as superior ability in cartilage
resurfacing and resistance to deterioration from inflammation and oxidation as well as angiogenesis in animal
studies. Our objective is to engineer “ideal” MSCs which can be prodigiously expanded and specifically
differentiated toward articular cartilage with a robust capacity to resist the harsh osteoarthritic environment by
preventing hypertrophic cartilage and fibrocartilage formation. To translate this finding into the clinical setting,
we will use cutting-edge CRISPR-Cas9 Genome Editing technology to introduce these factors by targeted
integration instead of using lentiviral vectors to improve the safety profile of this new therapy. This project has
the potential to bypass a critical bottleneck in articular cartilage regeneration by safely providing large
quantities of patient-specific functional chondroprogenitors that can survive a harsh osteoarthritic environment.

Public health relevance
Project Narrative Mesenchymal stromal/stem cells (MSCs) are a solution for cell-based cartilage repair, but cell senescence remains a challenge for yielding a sufficient number of high-quality MSCs for cartilage engineering. Most important, a harsh osteoarthritic environment is another challenge for successful chondral resurfacing of articular cartilage defects. The aim of this study is to design “ideal” MSCs using CRISPR-Cas9 Genome Editing technology to address the above concerns with minimized safety concerns in articular cartilage regeneration/engineering.